Analysis and therapy of age-dependent proteostasis failure in neurodegeneration

The previous period of Merit support allowed us to develop novel protocols for immuno-affinity isolation and
characterization of very pure protein aggregates. We began with C. elegans models of neurodegenerative
diseases, and then applied the same protocols to purify Aβ42- and tau-containing aggregates from affected
hippocampal tissue of Alzheimer's patients, seeking aggregate proteins that differentiate them from age-matched
controls. We now propose to apply our experience with these models to develop novel therapeutic agents that
might delay, prevent, or even reverse Alzheimer's and Parkinson's pathology, through the following Aims:
Aim 1. We have access through Dr. Sue Griffin, our collaborator, to a tissue bank of tissue samples from
Alzheimer's Disease (caudal hippocampus) and Parkinson's Disease (substantia nigra), from which we will
isolate aggregates by immuno-affinity for Aβ42, tau and α-synuclein. We propose to cross-link these aggregates,
thoroughly digest them with trypsin, and identify cross-linked peptide pairs that will reveal the protein-protein
interactions that mediated their conglomeration. We will use state-of-the-art “click chemistry” reagents to create,
tag and recover cross-link sites, and Xlink Identifier software to analyze mass-spectrometry data. To visualize,
integrate and interpret the protein-protein interactions thus revealed, we will create protein-interaction networks
and analyze them with tools adapted to the nonfunctional interactions that predominate in protein aggregation.
Aim 2. Proteomics data from Aim 1 will define critical protein-protein interactions within aggregates containing
tau, Aβ42 or α-synuclein, which are highly enriched in Alzheimer or Parkinson brain samples. These protein-
protein interactions will be ranked on the basis of their predicted propensity (by ΔG estimation) and stability (by
molecular-dynamic simulations). The top 10 protein interfaces from each pulldown will then serve as targets for
in silico screening of drug libraries developed to disrupt protein-protein interactions. Such libraries, constructed
in diverse ways, include many `PPII' drugs designed to block specific protein-pair interactions, but which have
frequently found applications beyond their original targets. For each target, we will perform initial screens of
PPII-library drugs in silico, from which the top candidates will be retested in molecular-dynamic simulations.
Aim 3. The drugs predicted in silico to most effectively disrupt key protein interactions (Aim 2) will be tested in
vivo for reduction of aggregate formation―first in human neuronal-cell cultures expressing APPSwe (forming
amyloid aggregates) or split-GFP::tau (fluorescing upon tau oligomerization). For drugs that are protective in
either assay, tests will also be conducted in C. elegans aggregation models expressing Aβ42, tau, or α-synuclein.
Biotinylated versions of 4–6 top candidates will be assessed for activity, and active biotinylated drugs will be
used to pull down proteins to which the drug attaches. This will be done initially in C. elegans, using an in-house
`genomewide' RNAi-knockdown library, and will then be cross-checked by introducing shRNA constructs into
cultured neuronal cells. Targets producing maximal protection will then be tested to ask whether drug efficacy
is partially redundant with RNAi knockdown, as expected for a target that mediates the drug's protective effects.
By discovery of novel drugs designed specifically to reduce aggregation, we expect to find far more effective
therapeutic and preventative agents than the limited drugs currently available. Based on our observations that
many aggregate components are shared among diverse neurodegenerative-disease models, at least some of these
drugs may also prove effective against a variety of other neurodegenerative diseases including orphan diseases.

Public health relevance
Some of the most devastating diseases of old age affect the brain and impair mental abilities. Veterans are at particular risk for the resulting dementias, due to advancing age or as a consequence of head traumas and perhaps exposure to chemical agents during active duty. Alzheimer's disease and other common neuropathies (Parkinson's, Huntington's, and Amyotrophic Lateral Sclerosis) all feature protein clumps or aggregates formed within or near brain cells. This research proposal is designed to learn what properties lead different proteins to adhere together, and to use this knowledge to guide the development of new pharmacologic therapies, drugs that are selected by several layers of screening for ability to reduce protein aggregation. Such drugs would be of immense benefit to veterans who suffer from head trauma (at exceptionally high risk for later dementia) as well as those currently diagnosed with a progressive dementia.